IND:138100. A phase I and surgical cohort Study of PTC596 in newly diagnosed children with DIPG and high-grade gliomas

ABSTRACT:
Diffuse intrinsic pontine glioma (DIPG) is a universally fatal brainstem tumor with survival <1 year
despite multimodal therapy. Similarly, other childhood high-grade gliomas (HGG) have a very
poor prognosis with 3-year overall survival (OS) of 10-22%. Recent studies have delineated
molecularly-distinct subgroups of pediatric HGG, including DIPGs, based on genomic/epigenomic
features with clinical and prognostic implications. Despite these strides, radiotherapy remains the
only standard therapy in pediatric HGG and DIPG, as no chemotherapeutic regimens have proven
effective. This underscores an urgent need for novel therapies to improve outcome in this
population. The B-cell-specific Moloney murine leukemia virus integration site 1 (BMI1) protein,
widely overexpressed in many cancers, has been implicated in self-renewal of normal and cancer
cells and in DNA-damage signaling. We have shown that BMI1 is highly expressed in DIPG,
(regardless of molecular subtype) compared to matched normal tissue and that BMI1
downregulation leads to inhibition of i) DIPG patient-derived neurosphere cell proliferation, ii) cell-
cycle signaling, iii) self-renewal, and v) DIPG cell migration. Our studies demonstrate that targeted
inhibition of BMI1 sensitizes DIPG cells to radiomimetic drug-induced DNA damage. Similarly,
BMI1 is highly expressed in pediatric glioblastoma (GBM) and its inhibition in in vitro and in vivo
models leads to growth inhibition and cell death. Collectively, our data identify BMI1 as a potential
therapeutic target for children with DIPG and HGG, setting the stage for clinical testing of BMI1
modulators such as PTC596. Pre-clinical studies from our group and others have demonstrated
in vitro and in vivo efficacy of BMI1 inhibitors, PTC209 and PTC596, in HGG, and DIPG, alone
and with radiomimetic agents. We propose to build on our pre-clinical studies to investigate the
molecular activity and therapeutic potential of BMI1 inhibition in children with newly-diagnosed
DIPG and HGG. The primary aims of this proposal are a) to determine the recommended
phase II dose (RP2D) of PTC596 given concurrently with radiotherapy in children with newly-
diagnosed HGG and DIPG, characterize its pharmacokinetics (PK); b) at the RP2D, to assess
PTC596 intratumoral PK and its ability to inhibit BMI1 activity in tumor in newly-diagnosed
DIPG/HGG children who receive PTC596 pre-resection/biopsy in a surgical molecular biology
study. This study will assess BMI1 activity and PTC596 PK in tumor and cerebrospinal fluid
among children with HGG and DIPG. The trial is being conducted through the Collaborative
Network of Neuro-oncology Clinical Trials (CONNECT). These data will be used in the rational
design of potential combination studies to improve outcome in children with DIPG and HGG.

Public health relevance
Project Narrative Pediatric high-grade gliomas (HGG) and diffuse intrinsic pontine gliomas (DIPG) are rare, have a dismal prognosis, underscoring the urgent need to develop novel therapeutic strategies to improve the outcome in children with these malignancies. The proposed phase I and surgical molecular biology study of the BMI-1 inhibitor, PTC596, will be conducted through the Collaborative Network for Neuro-oncology Clinical Trials (CONNECT). The ultimate goal is to use the data derived from this study to optimally design larger frontline studies using PTC596 in combination with radiotherapy and/or other cytotoxic or targeted therapies to improve the overall outcome in these particularly vulnerable groups of patients.